Dissecting the central and peripheral mechanisms to fentanyl induced respiratory depression

In this application we propose studies to assess how fentanyl complicates treatment of opioid overdose. In addition, our proposed studies might establish the mechanisms underlying fentanyl-induced respiratory depression. Overall, findings generated in this proposal will eventually lead to develop new therapeutic interventions to prevent and rescue fentanyl-induced fatal overdoses.

Public health relevance
PROJECT NARRATIVE In this application we propose studies to assess how fentanyl complicates treatment of opioid overdose. In addition, our proposed studies might establish the mechanisms underlying fentanyl-induced respiratory depression. Overall, findings generated in this proposal will eventually lead to develop new therapeutic interventions to prevent and rescue fentanyl-induced fatal overdoses.